Point-of-Care Monitoring of Adherence to Antiretroviral HIV Therapy

Point-of-Care HIV Viral Load, Drug Resistance, and Adherence Assays: The long-term goals of this program are to develop novel, low-cost, real-time point-of-care (POC) assays for 1. HIV Viral Load Monitoring; 2. HIV Drug Resistance Monitoring; and 3. Pharmacological Adherence Monitoring. This contract aims to develop an electrochemical POC test that will enable direct and label-free measurement of antiretroviral drugs in blood and urine samples.